Administrative Supplement: Medical Marijuana, Pain, and Opioid Use in Patients with Chronic Non-cancer Pain

PROJECT SUMMARY / ABSTRACT
Controversy exists over the risk-to-benefit ratio of medical marijuana (MM) for adults with chronic non-cancer
pain (CNCP) on chronic opioid therapy (COT). Approximately 50 million adults in the United States suffer from
CNCP, a debilitating medical condition that is complex to manage. The majority of those with CNCP are
treated with COT, but the evidence supporting long-term effectiveness of opioid drugs for pain and improved
functional status is weak, and high-dose COT greatly increases risk for opioid use disorder (OUD) and opioid
overdose death. Because of the complex medical needs of this patient group, there has been enthusiasm over
the potential to treat CNCP with MM. However, evidence to support the effectiveness of MM to either treat
chronic pain, or to reduce opioid use, is weak, and there are risks associated with MM. Thus, the issue of
whether CNCP patients using opioids should use MM as an adjuvant therapy to COT remains controversial,
and there have been no randomized studies that have directly addressed this question. We propose to enroll
250 adults who endorse >6 months of CNCP with neuropathic pain, have received COT at a dose of 50-300
MME/day for >90 days, who have not used but are considering use of MM, and who report interest in tapering
their COT dose, into a randomized, pragmatic 3 site trial. Participants will be randomly assigned to begin MM
at enrollment or to a waitlist control condition (WL), and not initiate MM for 24 weeks. All participants will be
offered a 24-week, manualized behavioral prescription opioid taper support (POTS) program. We will evaluate
whether patients with CNCP on COT who are assigned to MM+POTS, compared with those assigned to
WL+POTS, show (1) greater COT dose reduction (MME/day), and/or greater improvement in pain severity on
a pain numeric rating scale (co-primary outcomes), (2) improved quality of life, (3) improved pain interference,
depression, and anxiety; and (4) improvement in cognitive functioning (working memory, attention, and
executive function performance), from baseline to 24 weeks. We will also assess the development of CUD in
those using MM. Urine collected at each visit will be assessed quantitatively for cannabis metabolites. The
proposed study will answer a timely and significant public health question regarding whether MM use with
behavioral support, compared to behavioral support alone, is beneficial or harmful for this population. This
information is critical for patients, healthcare providers, and policymakers to evaluate the risks and benefits of
MM as an adjuvant treatment to COT for CNCP.

Public health relevance
PROJECT NARRATIVE Controversy exists over the risk to benefit ratio of medical marijuana for adults with chronic non-cancer pain (CNCP) on chronic opioid therapy (COT). The primary goal of this proposal is to assess whether medical marijuana, when added to a behavioral prescription opioid taper support program, improves pain and reduces opioid dose in adults on COT for CNCP more so than the behavioral intervention alone. This information is critical to better inform patients and clinicians about the extent to which medical marijuana use may be beneficial or harmful to this patient population.